NONSTEROIDALS EFFECTS UPON RENAL FUNCTION IN CHRONIC RENAL FAILURE

An evaluation of the effects of piroxicam, sulindac, and ibuprofen upon renal function and renal prostaglandin production in patients with mild, stable chronic renal failure.